Zeiss LSM 980 Confocal Microscope System

Project Summary/Abstract
The Life Science Initiative and the RNA Institute of the State University of New York at Albany (UAlbany)
represent a regional hub for multidisciplinary and collaborative research by undergraduate and graduate
students, post-doctoral fellows, research staff, and faculty. This highly interactive institution operates on a
dynamic collaborative approach toward scientific discoveries and high-quality education. To continue our
faculty’s historic interdisciplinary collaborative research ventures through our shared core research facilities,
we have identified an urgent need for a Zeiss LSM 980 confocal microscope system with the latest Airyscan 2
technology. This advanced quantitative fluorescence microscopy is capable of fast image acquisition with
ultrahigh spatial resolution and multispectral imaging at high spectral resolution. Acquisition of this advanced
imaging platform will facilitate a wide variety of research programs across our major and minor user groups
encompassing diverse fields including stem cell biology; cell-cell communication in organ development;
neuronal development and behavior; microbial communities in human health; gene regulation and
transcriptional activation; epitranscriptomic regulation by viral infection, environmental, and physical stress;
protein biosynthesis and translational regulation. The most advanced imaging systems currently available at
UAlbany, the conventional confocal Zeiss LSM710 fluorescence microscopy and two-photon fluorescence
microscope, lack sufficient resolution, sensitivity and speed to support these multidisciplinary cutting-edge
research programs. Our major users, in particular, require the Zeiss 980 superior resolution and imaging
capacity to answer critical research questions that are central to their research programs, including: 1)
understanding the interactions between niche cells and stem cell daughters responsible for cell differentiation;
2) defining the cell-cell and cell-ECM interactions that regulate organ-formation and regeneration in disease; 3)
understanding the development and regeneration of sensory neurons and GnRH-1 neurons in homeostasis
and disease, and 4) defining systems level structure-function relationships in the oral microbiome. The imaging
system is also critical to support the diverse research programs of our many minor users to acquire
multispectral data, high resolution images, and fast time-lapse images to answer critical research questions.
The excellent upgrade capabilities of this system will enable our program’s major and minor users as well as
the broader research community of New York’s capital region to meet the imaging research needs of their
cutting-edge research programs.

Public health relevance
Project Narrative Monitoring how biological events unfold within a cell, organ, or entire organism is of vital importance in understanding molecular and cellular processes and how defects can lead to human disease. Acquisition of the Zeiss 980 confocal microscope system, and its capacity for for multi-spectral imaging of live cells at high spatial resolution, will transform multiple research programs that span a diverse range of fields including microbial communication networks, neurodegenerative diseases, organ and tissue development, environmental stress, cell-cell communication, and transcriptional regulation.